CANCER CONTROL SCIENCE PROGRAM OF FOX CHASE CANCER CENTE

The Cancer Control Science Program of the Fox Chase Cancer Center is designed to complement the existing cancer control program and basic research efforts at the center. Prior cancer control research has included hypothesis development, descriptive studies and demonstration efforts. The scope of this initiative includes primary and secondary prevention, as well as management of the cancer patient. The ongoing research projects are: 1)\Cancer Control in an Urban Neighborhood; 2) Cancer Education Program for Older Citizens; 3) Cancer Education and Management for Patients. The primary hepatocellular carcinoma prevention studies have been continued as a developmental study. In addition, studies are planned in the Philadelphia urban neighborhoods on lung cancer epidemiology and on dietary habits and cancer. A study using physicians' offices for smoking cessation activities is planned. The resources and support of this CCSP program include a core group of investigators in medical oncology, biostatistics, epidemiology, social science, health education and health planning. The shared resources for this program include the statistical laboratory, the cancer information service and education and program evaluation.